Evaluation of PARP7 dependency as a novel therapeutic target for non-small cell lung cancer

ABSTRACT
Environmental exposure and tobacco use among US Veterans operate together to increase their lung cancer
risk. Despite significant progress in tumor- and immune-targeted therapies, lung cancer remains the leading
cause of cancer death in US Veterans, the US and worldwide. Non-small cell lung cancer (NSCLC) comprises
approximately 85% of all lung cancers. Identifying and evaluating novel therapeutic targets in NSCLC that could
simultaneously harness tumor-intrinsic and host immune-mediated mechanisms to promote antitumor responses
could have a major impact on treatment and clinical outcomes. Our integrated bioinformatics analyses identified
PARP7 Poly (ADP-Ribose) Polymerase 7 (PARP7) as a candidate therapeutic target with an estimated 40%
dependency in NSCLC. A recent study further demonstrated that targeting PARP7-dependency elicited potent
antitumor effects through both tumor-autonomous and host immune-stimulatory mechanisms via enhanced type
I interferon (IFN) signaling. However, the prevalence of PARP7-dependency in NSCLC primary tumors is not
known, and current clinical trials of a PARP7-specific inhibitor, RBN-2397, are not guided by assessment of
PARP7-dependency. There is no diagnostic platform to assess the status of PARP7-dependency, which is not
driven by oncogenic mutations. It is not known whether type 1 IFN signaling is the predominant mechanism that
drives the biology of PARP7 inhibition. PARP7 has been implicated as a critical factor to maintain the stemness
of embryonic stem (ES) cells, while the role of PARP7 in cancer stem cells (CSCs) has not yet been elucidated.
Our preliminary studies reveal that RBN-2397 induces transcriptome changes in PARP7-dependent human
NSCLC cell lines, patient-derived organoids (PDOs) from NSCLC surgical specimens as well as our murine
NSCLC models. These genes include both IFN downstream genes and genes implicated in cancer stemness,
inflammation, cell proliferation and apoptosis, which may serve as novel mediators of PARP7 inhibition-induced
antitumor effects. Our pilot single cell RNA-sequencing (scRNA-seq) studies with PARP7-dependent human
NSCLC cell lines demonstrated the feasibility of utilizing the scRNA-seq approach to identify common gene
signatures. In this proposal, we aim to accomplish the following objectives, utilizing both NSCLC surgical
biospecimens and our novel murine NSCLC models: 1) Reach a clinically relevant estimate of PARP7-
dependency in NSCLC; 2) Develop a diagnostic platform for the assessment of PARP7-dependency that
is sensitive and clinically translatable; 3) Understand the mechanism of PARP7 inhibition-induced
antitumor effects via type 1 IFN signaling as well as potentially novel mediators. We will evaluate the
prevalence of PARP7-dependency in NSCLC by both PARP7 CRISPR fitness assays and response to RBN-
2397, utilizing both primary tumor cells and PDOs derived from primary NSCLC samples. We will utilize NSCLC
surgical specimens with established PARP7-dependency to develop a scRNA-seq-based diagnostic platform
that combines both functional readout of drug cytotoxicity and transcriptome signatures. We will define both type
1 IFN pathway-mediated and novel mechanisms of PARP7 inhibition-induced antitumor responses in NSCLC,
including tumor cell-autonomous, host immune-stimulatory, and CSC-mediated effects, utilizing PDOs and
murine NSCLC models. Findings from these studies will provide a better understanding of the prevalence and
mechanisms of PAPR7-dependency in NSCLC, and facilitate future clinical evaluation of targeting PARP7-
dependency as a novel treatment strategy for NSCLC.

Public health relevance
Lung cancer is the leading cause of cancer death among US Veterans. The Veteran population has a higher age-adjusted incidence of lung cancer, a younger age at diagnosis, and higher rates of tobacco use as well as other military-related exposures to chemical carcinogens. Novel strategies targeting newly defined cancer dependency have the potential to provide effective treatment options for lung cancer patients, including US Veterans. The goal of this application is to evaluate PARP7-dependency as a novel therapeutic target for non- small cell lung cancer (NSCLC). We will assess the prevalence of PARP7-dependency in NSCLC utilizing primary surgical samples. We will develop a diagnostic platform to assess PARP7-dependency for effective patient selection. We will study the mechanisms of PARP7 inhibition-induced antitumor effects via type 1 interferon signaling as well as novel downstream effectors as potential mediators. These studies will provide critical guidance for future clinical evaluations of targeting PARP7-dependency as a novel strategy for NSCLC.